PROGRAM REVIEW/DEVELOPMENT SERVICES

Professional services to conduct frocess evaluationsfor the NCRR CTSA consortium. The objective of this effort is to provide the NIH with a overview of the best business practices as it relates to starting a new center program.